Targeting mutant estrogen receptor driven breast cancers

Project Summary/Abstract
A majority of Breast cancers (BC) express estrogen receptor alpha (ERα). While endocrine therapies
targeting either estrogen production or ERα are effective, acquired resistance is common. Sequencing of
metastatic endocrine therapy-resistant (ETR) tumors has shwown that ERα mutations are frequent (30-40%), do
not respond to endocrine therapies and are the molecular drivers of ETR-BC. Thus, drugs designed to
specifically target these ERα mutations in ETR-BC represent a significant unmet clinical need.
We leveraged the recent structural characterization of the mutant ERα ligand binding domain (LBD) to
rationally design bis-benzamides to fit the binding pocket. Following iterative rounds of modeling, synthesis,
testing and optimization with >2000 bis-benzamides, we have identified a lead compound, ERX-315, that binds
more avidly to ERα LBD. Our preliminary studies showed that ERX-315 has potent anti-proliferative activity
against mutant ERα-driven tumors, as seen in genetically modified cell lines in vitro, patient derived explants
(PDEs) ex vivo and patient derived xenografts (PDXs) in vivo. Importantly, a methylated version of ERX-315,
ERX-314 binds the mutant ERα poorly and does not affect proliferation of these tumors. Ultrastructural and
molecular studies reveal that ERX-315, but not ERX-314 (a methylated version of ERX-315, does not bind ERα,
serves as a negative control) induces significant endoplasmic reticulum stress, leading to a shutdown of de novo
protein synthesis and apoptotic cell death in BC. Importantly, ERX-315 does not induce endoplasmic reticulum
stress or cell death in normal cells and is non-toxic in animal models. We have shown that this capacity of ERX-
315 to induce endoplasmic reticulum stress is unique among drugs targeting ERα, including selective ERα
modulators and degraders, such as GDC-0180, AXD-9496 and fulvestrant.
The objective of this direct Phase II SBIR proposal is to enable EtiraRx to perform IND-enabling studies
for clinical translation of ERX-315 in ETR-BCs. We have shown that ERX-315 has favorable pharmacologic
parameters for clinical translation and is amenable to good manufacturing practice manufacturing. In Aim 1, we
will we will perform dose-ranging finding studies in two species and define maximum tolerated dose and toxicity
at that dose. In Aim2, we will synthesize large-scale batches of ERX-315 and will perform single- and multi-dose
pharmacokinetic studies and evaluate tissue biodistribution. We will define 30-day toxicity in rats and dogs with
a 2-week recovery, and evaluate functional recovery, cardiovascular and respiratory safety. In Aim 3, We will
test the efficacy of clinical grade ERX-315 in biologically and clinically relevant preclinical models of ETR-BC,
including patient derived xenografts and patient derived explants. The intellectual property around ERX-315 is
protected by multiple patents licensed to EtiraRx. a novel small molecule targeting mutant ERα, and with an
unique ability to induce endoplasmic reticulum stress and apoptotic cell death. If successful, our proposed
studies will enable within 2 years the first-in-class studies with ERX-315 in women with ETR-BC.

Public health relevance
Project Narrative EtiraRx has licensed a first-in-class drug (ERX-315) that was designed to target the mutant forms of the estrogen receptor and induce cytotoxic cell death through a novel mechanism of enhancing endoplasmic reticulum stress. Funding from the SBIR will enable completion of critical preclinical studies for ERX-315, and accelerate progress towards a first-in-man clinical trial of a drug designed to target the mutant estrogen receptor or the major driver of endocrine therapy resistance and metastases in breast cancer